Administrative Core

Contact PD/PI: HALPERN, SCOTT
ADMINISTRATIVE CORE SUMMARY
The University of Pennsylvania (Penn) Patient-Oriented Research and Training to Accelerate
Learning, or Penn PORTAL, aims to (1) train Learning Health System (LHS) Scientists with personal,
disciplinary, and institutional diversity; (2) catalyze LHS research by building and connecting data assets
and supporting scientists to complete stakeholder-prioritized projects; and (3) test interventions among
representative patient populations in several priority areas and ensure their equity before implementation
across health systems. The Administrative Core (AC) will deploy specific tactics and structures in support
of each of these aims. First, the AC will be housed within the Palliative and Advanced Illness Research
(PAIR) Center led by MPI Halpern, thus reducing administrative costs by leveraging PAIR’s established
business office and senior staff to provide central administrative support to implement, monitor, and
financially support all PORTAL activities. Second, the AC will build synergies among our Research
Education Core (REC) and Research and Data Analysis Core (RDAC), partnering centers and institutes,
and other entities that bring complementary expertise in all domains relevant to LHS science. Third, the
AC will foster inclusion, diversity, equity, and engagement in all aspects of PORTAL by establishing an
Equity and Community Engagement (ECE) unit within the AC.
Central to the AC’s effort will be an 11-person Steering Committee comprising the three MPIs (Drs.
Halpern, Lane-Fall, and Delgado), the ECE lead (Dr. Aysola), PORTAL’s program manager, and six other
senior faculty who hold key leadership positions in the medical school and health system. The Steering
Committee will be responsible for executing the first AC aim by setting the overall direction for PORTAL,
issuing requests for proposals from LHS Scientists, and making decisions, with input from the REC Co-
leads and the LHS Design Studio and Operations & Implementation Committee in the RDAC, on which
Scientists and research projects to prioritize. The Steering Committee will also coordinate and set agendas
for our twice-annual meetings with our Internal Advisory Board and External Advisory Board, and oversee
the dissemination of our Scientists’ progress and learnings. The MPIs will leverage their longstanding
tenures and broad connections at Penn to execute the AC’s second aim of building synergies among
Penn’s centers and institutes with complementary expertise relevant to LHS science. Finally, the ECE will
be primarily responsible for executing the AC’s third aim by building on its many years of experience
partnering with local and regional government officials and other Philadelphia health systems and
engaging community representatives from across the City so as to ensure that Penn PORTAL’s work
produces equitable improvements in patient-centered outcomes, is responsive to community needs, and
is scalable across our partnering health systems.